Weight Regulation by GLP1R agonists via a non-canonical hypothalamic PKA-mTORC1 mediated pathway

PROJECT SUMMARY/ABSTRACT
Glucagon-like peptide-1 receptor (GLP1R) agonists are an emerging class of drugs used to treat obesity due to
their ability to lower body weight. While GLP1R action in the brain is essential for the weight-lowering effect of
these drugs, little is known about the molecular mechanisms engaged by GLP1R agonists that promote weight
loss. Studies conducted by our group made the novel discovery that the GLP1R agonist liraglutide stimulates
activity of the nutrient-sensing protein complex mechanistic Target of Rapamycin Complex-1 (mTORC1) via
phosphorylation of the mTORC1 accessory protein Raptor in Serine791 by the canonical GLP1R signaling target
protein PKA. Furthermore, we show that global mutation of Serine791 in Raptor renders mice partially resistant
to liraglutide-induced weight loss, indicating that this signaling mechanism contributes to the anorectic effect of
GLP1R agonists. The goal of this project is to identify the key neuronal population and circuit in which GLP1R
agonists engage this non-canonical PKA-mTORC1 interaction to promote weight loss. I hypothesize that
GLP1R agonists promote weight loss by stimulating the PKA-mTORC1 interaction in
Proopiomelanocortin (POMC) neurons of the Arcuate nucleus of the hypothalamus (ARCPOMC) that
synapse onto Melanocortin- 4 Receptor-expressing neurons in the Paraventricular nucleus of the
hypothalamus (PVHMC4R). The focus on ARCPOMC neurons is based on our preliminary findings that deletion
of the GLP1R in POMC neurons significantly attenuates liraglutide-induced weight loss. ARCPOMC neurons
synapse onto PVHMC4R neurons, and activation of this ARCPOMC → PVHMC4R circuit promotes weight loss.
However, it is not known whether GLP1R- expressing ARCPOMC neurons form part of this functional ARCPOMC
→ PVHMC4R circuit. I will test my hypothesis using sophisticated genetically encoded protein activity reporters,
transgenic mouse lines, imaging analyses, circuit mapping approaches, and metabolic phenotyping techniques.
Aim 1 tests whether GLP1R activation specifically in ARCPOMC neurons promotes weight loss through the PKA-
mTORC1 pathway. This includes in vivo measurements of PKA activity in ARCPOMC neurons in freely moving
mice in response to GLP1R agonist treatment as well as performing comprehensive metabolic phenotyping tests
in novel transgenic mice expressing a PKA-resistant Serine791 Raptor mutant specifically in POMC neurons.
Aim 2 investigates whether GLP1R- expressing ARCPOMC neurons form an anatomical and functional
ARCPOMC → PVHMC4R neurocircuit regulated via the PKA-mTORC1 signaling pathway in ARCPOMC
neurons. This will involve rabies-virus based monosynaptic circuit mapping approaches and functional tests of
neuronal activity. Completion of the experiments proposed in this application will provide me with extensive
training in experimental design and data analysis and interpretation as well as in mastering concepts and
methods relevant to neuroendocrinological regulation of metabolic phenotypes. My Sponsor and co-Sponsor are
fully committed to my training and to helping me develop into an independent academic research scientist.

Public health relevance
Project Narrative Glucagon-like peptide-1 receptor (GLP1R) agonists represent a new class of effective therapeutics for reducing body weight and combating obesity. As the use of these drugs to treat obesity is likely to increase significantly, a clear delineation of the molecular mechanisms mediating the weight-lowering effect of GLP1R agonists will be informative should undesirable side effects emerge with their long-term use and/or we need to identify novel targets to promote weight loss. The proposed research project aims to elucidate the signaling mechanism by which GLP1R agonists activate a specific neural circuitry that controls feeding behavior and will provide me with the necessary training opportunities to further my career goal of becoming an interdisciplinary neuroscientist.